HUMAN DENDRITIC CELLS/CHEMOKINES TO ENHANCE IMMUNE RESPONSE

The purpose of this project application is to bring together adoptive immunotherapy, gene transfer, dendritic cell (DC) isolation and use, and chemokine biology to develop and implement a novel strategy to ultimately treat patients with melanoma and colorectal cancer through the combined use of autologous tumor-pulsed DC and chemokine-secreting gene modified fibroblasts.